FEASIBILITY ON INTENSIVE INSULIN THERAPY IN CHILDREN WITH NEWLY DIAGNOSED IDDM

This is an investigator initiated, randomized, controlled clinical trial. The feasibility, risks, and benefits of intensive insulin therapy in 40 children (6-18 years old) with newly-diagnosed type I diabetes mellitus will be evaluated over a 2 year period. Subjects will be randomly assigned to conventional or intensive insulin therapy. Success of therapy, risk of hypoglycemia, and residual beta-cell function, as measured by C-peptide response to Sustacal, will be evaluated.